Child Health Research Career Development Award (CHRCDA) Program (K12)

PROJECT SUMMARY / ABSTRACT
The goal of the Boston Children's Hospital K12 CHRCDA Program is to develop independent pediatrician
physician-scientists who will decipher the pathobiology of childhood disease and develop transformative new
therapies. Our Scholars will perform laboratory-based basic and translational research under the mentorship of
outstanding scientists at Boston Children's Hospital and other affiliated institutions. Our program has been
established to ensure the continued development of outstanding independent pediatrician-scientists in the field.
In this proposal, we describe a program that includes intensive mentoring, a comprehensive didactic program,
and appropriate supervision and support to ensure that our Scholars reach their maximum scientific potential.
Programmatic oversight will be provided by an External Advisory Committee and an Internal Steering Committee.
Plans are in place for programmatic self-evaluation and for review of Scholar Progress. We propose to continue
the funding of three Scholar positions. Scholars will be funded for a minimum of two years, contingent on
satisfactory progress on research and career development activities, and the overall pool of Scholar candidates.
Scholars will be faculty members most often at the rank of Instructor, but Assistant Professors who are early in
the development of their independent careers will also be eligible to apply. Scholars will be considered at any
point from the beginning of their Instructorship until they are considered to be two years away from submitting
their first R-level NIH grant or equivalent, though no more than four years beyond the end of fellowship training.
Scholars will work in broad areas of scientific investigation relevant to child health. Past and present Scholars
have studied the genomics of rare childhood disease, developmental biology, mucosal immunology, host-
microbe interactions, monogenic kidney diseases, genetics of epilepsy, and environmental effects on early brain
development. Our Scholars are expected to elucidate molecular mechanisms of disease, leading to the
development of transformative new therapies for a broad range of diseases of childhood.

Public health relevance
PROJECT NARRATIVE The Department of Pediatrics at Boston Children's Hospital is dedicated to the training of physician-scientists and helping them develop into world-class independent scientists and future leaders in the field. We have a strong track record of training physician-scientists who have gone on to make fundamental discoveries in basic and translational research, which have had a lasting impact on the treatment of pediatric disease. The Child Health Research Career Development Award program has played an integral role in our ability to support the development of physician-scientists at our institution and we propose to continue and strengthen this program over the next five years.